Skeletal Muscle Loss and Dysfunction

PROJECT 4: Skeletal Muscle Loss and Dysfunction – SUMMARY LeBrasseur
In line with the overall goal of the Program Project Grant, Project 4 will test the central hypothesis that
senescent cells mechanistically contribute to skeletal muscle aging and represent a novel druggable target to
restore muscle performance, physical function, and organismal resilience. Our hypothesis is founded on our
recent work demonstrating the role of cellular senescence, a hallmark of aging, in the genesis of multiple age-
related conditions. Our preliminary data demonstrate expression of the cyclin-dependent kinase inhibitor
p21Cip1, a marker and mediator of senescence, increases in aged murine and human skeletal muscle and
negatively associates with measures of physical function. We show that p21Cip1, senescence-associated
secretory phenotype (SASP), and anti-apoptotic proteins markedly increase in cultured myoblasts in response
to senescence-inducing stress. Aged muscle is compositionally heterogenous, however, and senescence of
other resident cell populations, including fibroadipogenic progenitor, endothelial, and immune cells, may also
contribute to its degeneration. Consequently, there is a critical need to identify and comprehensively phenotype
the cell populations within aged muscle that senesce and mechanistically contribute to its loss and dysfunction.
To this end, in Aim 1 we will use mice harboring a transgene that enables the isolation of p21Cip1-expressing
cells to quantify markers of senescence, the SASP, and anti-apoptosis pathways in muscle-resident cells of
young and aged mice. High dimensional mapping of non-senescent and senescent cell populations will be
accomplished through mass cytometry and advanced histological approaches. Aim 2, will directly compare the
effects of genetic clearance of p21Cip-expressing cells to clearance of p16Ink4a-expressing cells on muscle
health (e.g., mass, fibrosis, and fat infiltration) and measures of physical function and resilience with the
support of Integrated Healthspan Phenotyping Core. We will also assess the relative efficacy of clearing
specific p21Cip1-cell populations using novel Cre-LoxP lines and pharmacological agents developed and
screened by the Drug Discovery and Development Core. Finally, Aim 3 will test the hypothesis that genetic and
pharmacological clearance of senescent cells will potentiate the effects of a muscle building drug on measures
of muscle health, physical function, and resilience. Secondary analyses will include the effects on metabolic,
bone, and cardiovascular health in partnership with Projects 1, 2, and 3, respectively. Through the use of novel
analytical, transgenic, and pharmacological tools and a multidisciplinary approach, we expect to advance our
understanding of the fundamental biology of skeletal muscle aging. The application of clinically-relevant
measures of physical function and resilience and evidence-based senotherapeutic compounds will facilitate the
translation of preclinical discoveries to clinical application.